Exposure and Response Prevention to Improve Functioning in Veterans with Obsessive Compulsive Disorder

Project Background
Exposure and Response Prevention (ERP) is the gold standard evidence-based psychotherapy for OCD;
however, few Veterans receive ERP and no randomized controlled trials (RCTs) have been published
examining the effectiveness of ERP among Veterans or in individuals with comorbid OCD and posttraumatic
stress disorder (PTSD). OCD impacts work, social, and family functioning, such that 38% of people with OCD
are unable to work due to the severity of symptoms and 25% attempt suicide at some point in their lives
(Mancebo et al., 2008). It is essential to examine the effectiveness of ERP in Veteran specific trials because
Veterans are a complex, highly comorbid population, and have significant trauma histories which can
complicate ERP treatment. Many Veterans face logistic barriers to accessing therapy including transportation,
distance, childcare, and work, in addition to challenges leaving the home due to OCD symptoms. Video
telehealth (VTH) can increase Veterans’ access to ERP and may enhance the generalizability of exposures
since in-home exposure exercises can focus on OCD triggers that people encounter in their home
environment. This may mean more direct impact to the Veteran’s daily life functioning and quality of life.
Project Objectives
The proposed 4-year multisite RCT will compare outcomes of VTH-delivered ERP to those of a stress
management training control condition among 160 Veterans with OCD. Half of the sample with have comorbid
PTSD. The primary aim will examine whether participants’ functioning, quality of life, and OCD symptoms differ
as a function of the intervention (ERP vs. control). The secondary aim will examine these outcomes among the
half of the sample with comorbid OCD and PTSD. The tertiary aim is to conduct a mixed-methods formative
evaluation of the implementation potential of ERP in VA mental health settings.
Project Methods
Eligible Veteran participants will be randomized to ERP or to the control condition. Veterans randomized to
ERP will receive 16 weekly ERP sessions delivered via VTH. Control participants will receive 16 weekly
sessions of a stress management training intervention delivered via VTH. Participants in both conditions will
complete assessments at post-treatment and 6 months after completing treatment. Participants in the ERP
condition will also complete an assessment of treatment satisfaction and a qualitative exit interview assessing
the Veterans’ perceptions of the impact of treatment on multiple domains of functioning, including the impact
on PTSD symptoms. Providers and VA administrators will participate in qualitative interviews regarding the
implementation potential of ERP in VA.
Contribution to VHA
This work addresses RR&D clinical priorities related to cognitive-behavioral interventions for improving
Veterans’ functioning, participation in society, and quality of life. Establishing ERP as an evidence-based
treatment in the complex Veteran population has the potential to impact the 170,000 Veterans in VHA with
OCD and assist them in living more functional lives, which will affect their families, children, workplaces, and
communities.

Public health relevance
Obsessive compulsive disorder (OCD) is a debilitating psychiatric illness impacting work, social, and family functioning. Exposure and Response Prevention (ERP) is the sole evidence-based psychotherapy for OCD; however, no randomized controlled trials (RCTs) have examined the effectiveness of ERP among Veterans or individuals with both OCD and posttraumatic stress disorder (PTSD). The proposed 4-year RCT will compare outcomes of ERP to those of a stress management control among Veterans with OCD. Primary and secondary aims will examine whether Veterans’ functioning, quality of life, and OCD symptoms differ between the ERP and control in the full sample of Veterans with OCD, and in the half of the sample with both OCD and PTSD. The tertiary aim is to conduct a mixed-methods formative evaluation of the implementation potential of ERP in VA mental health settings. This work addresses RR&D clinical priorities related to cognitive-behavioral interventions for improving Veterans’ functioning, participation in society, and quality of life.